Crosslinking conjugates to localize and activate NK cells in glioblastoma

The immune response to cancer is marked by inadequate activation of immune cells and their poor targeting of tumors. This is very much the case with glioblastoma (GBM), the most common and lethal primary brain tumor. This proposal aims to tackle both issues with novel immunoconjugates designed to simultaneously activate circulating natural killer (NK) cells while also linking them to tumor blood vessels or directly to cancer cells. Each of these leukocyte-endothelial/cancer crosslinkers (LECCs) consists of two biotinylated antibodies conjugated by an avidin; half the antibodies bind either the activating NKG2D or CD16 receptors on NK cells and the other half bind to the αvβ3 integrin expressed on both tumor vascular endothelial cells and many cancer cells. The conjugates are extremely stable and easy to synthesize in the laboratory. Our preliminary data already indicate promising activity of the NK LECC. This proposal will test the ability of the NK LECC in vitro to trigger NK cell binding and killing of GBM cells and GBM endothelial cells, as well as its in vivo biological effects and efficacy. Successful completion of the proposed work should yield a novel and easily translatable immunotherapy with activity not only against GBM but potentially against most cancers. Furthermore, this approach can easily be extended to recruit other leukocyte types and target other markers on tumor vasculature and cancer cells.

Public health relevance
Without assistance the immune system ultimately fails to recognize and destroy cancer, but recently some immunotherapies have proven effective for cancers such as melanoma. Early results of these immunotherapies for patients with glioblastoma have been disappointing, however, underscoring a need for novel immunotherapy approaches to this most common and lethal brain tumor. This proposal investigates a new approach to immunotherapy, using antibody conjugates both to activate circulating “natural killer” (NK) cells and to bind them to the glioblastoma blood vessel walls and to the glioblastoma cells themselves. This should result in immune cell killing of the glioblastoma blood vessels as well as the glioblastoma cells. Our early results in a mouse model of glioblastoma already show promising effectiveness. The studies of this application will assess the immunologic effects of the NK cell cross-linking conjugate both in cell culture models and in a mouse brain tumor model. This pilot project has the potential to generate a completely novel cancer immunotherapy to more effectively treat glioblastoma and other cancers as well.